α9α10 Nicotinic Acetylcholine Receptors in neuropathic pain

ABSTRACT
Chronic pain represents a serious and growing health concern that affects at least one in five
American adults. Despite the high risk of tolerance, physical dependence, and addiction, opioid
analgesics continue to be a major component of pain management. Furthermore, opioids are only
weakly effective for the approximately 30-40% of chronic pain patients suffering from neuropathic
pain arising from lesions or disease of the somatosensory nervous system. Non-opioid first-line
treatments for neuropathic pain are also only marginally effective and suffer from serious adverse
effects. Clearly, there is an urgent need for new analgesic drug targets and for new classes of
drugs that can effectively and safely treat neuropathic pain. The long-term goal of this research
project is to fill this gap by establishing the role of the α9α10 nicotinic acetylcholine receptor
(nAChR) in neuropathic pain and developing effective antagonists against it. Evidence from
peptidic α9α10 antagonists and α9-knockout mice indicates that inhibition of α9α10 function
successfully attenuates allodynia and hyperalgesia in several animal models of neuropathic pain.
However, the poor drug-like properties of existing α9α10 antagonists hinders them from being
easily translated into the clinic. Previous efforts to discover novel α9α10 ligands have been
thwarted by technical challenges in adapting α9α10 nAChRs for high-throughput screening and
compound optimization assays. Furthermore, the difficulty in expressing α9α10 in mammalian
cells has left unanswered questions regarding the structure and function of this promising drug
target. Building on a recent discovery that TMIE is an essential auxiliary protein for α9α10 receptor
expression, we have engineered a novel HEK293 cell line that stably expresses functional α9α10
receptors. The objective of this application is to leverage this innovative cell line to develop novel
α9α10 antagonists and interrogate the location, function, and structure of the receptor. Moreover,
we will investigate the in vivo efficacy of pharmacological inhibition of α9α10 activity in multiple
neuropathic pain models in mice, studying both spontaneous pain and evoked hypersensitivity.
The results from these studies will provide strong evidence that α9α10 nAChRs play a causal role
in driving neuropathic pain and represent a bona fide target for analgesia, and will deliver
promising lead compounds targeting this mechanism.

Public health relevance
NARRATIVE Current medications for the treatment of neuropathic pain are only marginally effective and suffer from serious, sometimes life-threatening, side effects. Inhibiting the activity of the α9α10 nicotinic acetylcholine receptor is emerging as a promising strategy to treat neuropathic pain; however, technical challenges have limited the investigation of this receptor and prevented the discovery of drugs that target it. This project overcomes this historical hurdle in α9α10 drug discovery to identify novel α9α10 antagonists and provide strong evidence to support their future development into new treatments for neuropathic pain.